Pharmacokinetic and Pharmacodynamic Modeling of Anticanc

In order to optimize therapy, a full understanding of the pharmacokinetics of any systemic therapy is desired. We routinely model the pharmacokinetics of agents being tested for antitumor activity and correlate that with activity and/or toxicity (pharmacodynamics modeling). The laboratory is currently collaborating on 45 clinical trials to characterize the clinical pharmacology of novel chemotherapy agents.